Adhesion G Protein-Coupled Receptors in CNS Development and Regeneration

PROJECT SUMMARY/ABSTRACT
Please see Research and Career Plan.

Public health relevance
PROJECT NARRATIVE The myelin sheath surrounding axons is essential for the proper function of the nervous system and its disruption causes many devastating diseases including multiple sclerosis. Ensheathment by premyelinating oligodendrocytes (pmOLs) is a critical first step of myelin formation. Here, we propose to study the role of pmOLs in white matter injury and repair.